Quantifying the impact of hyperglycemia on embryonic metabolism and development in C. elegans.

PROJECT SUMMARY
The objective of this project is to generate single cell resolution information about how metabolism changes at
single cell resolution over the course of embryonic development in embryos from normal and hyperglycemic
mothers. This is relevant to understanding why structural birth defects are 2-3 times more likely in pregnancies
of diabetic mothers. We will use the nematode C. elegans as a model in our studies and since many aspects of
development and metabolism are conserved, our findings will likely further our understanding how metabolism
affects morphogenesis in vertebrate embryonic development and human structural birth defects. C. elegans is
an excellent model because its simplicity and accessibility will enable us to fully characterize the cellular
metabolism of individual cells during embryonic development and determine how hyperglycemia impacts cell
fate specification and morphogenesis. Our preliminary data show that cellular metabolism varies across cells
and across developmental time. We hypothesize that maternal hyperglycemia increases oxidative stress in
embryonic cells, resulting in insufficient cellular energy for essential migrations and inducing AMPK-mediated
chromatin changes that inhibit the expression of cell fate TFs, resulting in developmental defects. To test this
hypothesis, we will use complimentary approaches of quantitative time-lapse imaging of biosensors, and
transcriptomics plus metabolic modeling. We will integrate the results from each approach to create a single
cell resolution profile of embryonic metabolism across developmental time in control and maternal
hyperglycemia embryos. This will enable us to link developmental defects to disruptions in metabolism at the
cellular level. This work will generate the first comprehensive metabolic atlas of a metazoan embryo with the
single cell resolution across developmental time and determine how embryonic cellular metabolism and
developmental processes are impacted by hyperglycemia.

Public health relevance
PROJECT NARRATIVE Diabetic mothers are 2-3 times more likely to have a pregnancy affected by birth defects, but how maternal hyperglycemia changes cellular metabolism to impact embryo development is not well understood. To better understand how maternal hyperglycemia impacts development, we will determine how cellular metabolism changes with maternal hyperglycemia throughout the embryonic development of the nematode worm, Caenorhabditis elegans, and determine how embryonic development is disrupted. Since many aspects of development and metabolism are conserved, our findings will further our understanding of how disruptions of metabolism affect embryonic development and may identify potential dietary interventions to prevent human birth defects.